Targeted Clinical Research Program to Address Selected Viral Infections

The Targeted Clinical Research Program to Address Selected Viral Infections supports the development of therapies for select rare and emerging viral diseases, and evaluates these candidate products in a variety of special patient populations, including pediatric patients. Study will address potential for drug resistance.